MODULATION OF SODIUM CHANNEL BLOCK BY ACE INHIBITION IN MAN

Data obtained in this study will provide the initial evidence of metabolic regulation of the cardiac sodium channel through the renin-ag system.